Statistical Methods for Ultrahigh-dimensional Biomedical Data

DESCRIPTION (provided by applicant): This proposal develops novel statistical methods to select a small group of molecules from high-throughput data such as microarray and proteomic data from cancer research. The challenge of the study is the ultrahigh dimensionality inherited in these studies, particular when gene-gene interactions are introduced. The ultrahigh dimensionality has large impact on statistical computation, methodological developments, and theoretical studies. The challenge will be dealt by using the proposed novel independence screening methods, which also addresses the computational demand and stability, and the issues of stochastic error accumulation in ultra-high dimensional statistical inferences. An iterative independence screening method is introduced to find hidden signature genes that are marginally unimportant but jointly extremely important to the clinical outcomes. It also enables us to eliminate redundant molecules that are marginally highly but jointly weakly associated with clinical outcomes. With number of features surely reduced to a manageable level, penalized pseudo-likelihood methods will be introduced to further select relevant genes. In addition, methods for finding synergetic groups of molecules are introduced. The idea of independence screening and its iterated version will be applied to various statistical problems from the analysis of high throughput data, ranging from ultrahigh dimensional regression and classification to the analysis of survival time, estimation of genewide variance, and normalization of microarrays. The efficacy of the proposed methods will be evaluated via asymptotic theory and simulation studies. Data sets from on-going biomedical studies on cancer such as breast cancer, multiple myeloma, neuroblastoma, lung tumor, and liver carcigogen will be critically analyzed using the newly developed statistical and bioinformatic tools. PUBLIC HEALTH RELEVANCE: Statistical Methods for Ultrahigh-dimensional Biomedical Data PI: Jianqing Fan This proposal develops novel statistical and bioinformatic tools for finding genes and proteins that are associated with clinical outcomes. Data sets from on-going biomedical studies on cancer such as breast cancer, multiple myeloma, neuroblastoma, lung tumor, and liver carcinogen will be critically analyzed using the newly developed statistical and bioinformatic tools. The research findings will have strong impact on understanding molecular mechanisms of cancer and developing therapeutic targets.

Public health relevance
Statistical Methods for Ultrahigh-dimensional Biomedical Data PI: Jianqing Fan Project Narrative (Part 7) This proposal develops novel statistical and bioinformatic tools for finding genes and proteins that are associated with clinical outcomes. Data sets from on-going biomedical studies on cancer such as breast cancer, multiple myeloma, neuroblastoma, lung tumor, and liver carcinogen will be critically analyzed using the newly developed statistical and bioinformatic tools. The research findings will have strong impact on understanding molecular mechanisms of cancer and developing therapeutic targets.